TRIAL OF VITAMIN E AND DONEPEZIL HCL TO DELAY CLINICAL PROGRESSION IN ALZHEIMER'S

The purpose of this study is to determine whether targeted medical interventions can impact the rate of conversion from MCI to AD in a high-risk population.